Genome-wide Analysis of Anticoagulant Heparin Sulfate for Bioengineering Heparan

Project Summary
Heparin is the most widely prescribed anticoagulant drug in the world and is used routinely for the treatment and
prevention of deep vein thrombosis and pulmonary embolism. Currently, therapeutic heparin is a fractionated
form of heparan sulfate derived from animal sources, predominantly from connective tissue mast cells in pig
mucosa sourced from China. While essential and widely used, heparin has significant adverse complications.
Approximately 600,000 patients per year treated with heparin in the USA develop a life-threatening condition
known as heparin-induced thrombocytopenia (HIT), which results from the formation of heparin-platelet factor 4
(PF4) immunoreactive complexes. Therefore, there is an urgent need for safer, alternative sources of heparin.
A recombinant source of heparin would be safer, avoid supply chain issues, and allow for the introduction of
biological modifications to prevent HIT. While the enzymes involved in heparin biosynthesis are identical to those
for heparan sulfate, there is a significant gap in knowledge regarding the regulatory mechanisms that give rise
to the anticoagulant activity and biosynthesis of heparin. Heparin inhibits coagulation by binding with high affinity
to the serine protease inhibitor, antithrombin (AT), and enhancing its activity to neutralize thrombin and Factor
Xa in the coagulation cascade. Additionally, heparin exhibits high affinity binding to PF4, a chemokine produced
by platelets, triggering HIT. Since PF4 binding to heparin depends on distinct binding sites compared to AT, we
hypothesize that cells could be engineered to produce anticoagulant heparan sulfate with decreased PF4 affinity
as a safer alternative to animal-derived heparin. Our previous studies have revealed distinct regulatory
mechanisms for heparin biosynthesis in cells, suggesting that other factors exist that regulate anticoagulant
heparin/HS production and modify AT and PF4 affinity. The goal of this proposal is to leverage our experience
in genome-wide screening assays to identify genetic factors that control heparin biosynthesis and can be utilized
for bioengineering anticoagulant heparan sulfate in cultured cells. To accomplish this goal, we aim to (i) adapt
genome-wide screening assays to search for novel factors that regulate AT and PF4 binding to cell surface
heparan sulfate, and (ii) validate prioritized hits from the screens and leverage these for metabolic engineering
of mammalian cells to produce anticoagulant heparan sulfate with lowered PF4 affinity. The successful
completion of these aims will provide a bioengineered cell line that produces a safer, recombinant form of heparin
and may also uncover previously unknown genes associated with heparin’s activity and assembly. Importantly,
this project will lead to future detailed hypothesis-driven studies that will bring us closer to finding an alternative
to animal-derived heparin for improving patient care and clinical outcomes by prevention of HIT.

Public health relevance
PROJECT NARRATIVE This proposal aims to study the regulatory mechanisms controlling heparin biosynthesis in order to bioengineer a safer, recombinant form of anticoagulant heparin in cultured cells. The research is highly relevant to public health because the recombinant heparin products generated in these studies represent new potential therapeutics for improving patient care and minimizing heparin-induced thrombocytopenia (HIT), a life- threatening, immune-mediated complication to heparin therapy.